Characterizing the Sensorimotor Transformation in Drosophila olfactory system

Characterizing the Sensorimotor Transformation in Drosophila olfactory system
Understanding how the nervous system transforms sensory inputs into motor commands is a
fundamental question in neuroscience. To understand how the nervous system performs these
complex sensorimotor transformations we must be able to provide a well-controlled stimulus
that elicits complex, multisequence behaviors and a means to quantitatively analyze this
behavior, as well as have a complete knowledge of the underlying neural circuitry involved in
this behavior. Here, we look to characterize the sensorimotor transformation occurring within
two olfactory receptor neuron (ORN) classes in Drosophila melanogaster and identify how they
impact behavior. Using an electron micrograph dataset of the fly brain we can identify the
connection patterns between the first-order neurons of the olfactory system and the downstream
second- and third-order neurons. The fly is highly tractable and we will use genetic strategies to
optogenetically activate this first-order ORN classes and record from the second- and third-
order neurons in response to this activation. By observing fly behavior in response to this ORN
activation we can determine the relationship between its selective activation and its impact on
behavior, as well as how the transformation between the first- to second- and second- to third-
order neurons impact this expressed behavior. By combining optogenetics, electrophysiology,
computational modeling, and behavior, this proposal seeks to further our understanding of how
the nervous system integrates sensory information to execute an accompanying motor plan.

Public health relevance
Project Narrative The goal of this proposal is to characterize how the neural signals encoding odor information for a biologically relevant segment of the fly olfactory system are transformed at critical points within this system. In doing so, we hope to identify how these signal transformations can be associated with changes in specific aspects of fly behavior, like whether they turn more or slow down when making sharp turns. By studying how these signals are transformed and how these transformations impact behavior, we hope to gain a better understanding of how the fly olfactory system influences the selection of specific motor programs during ongoing locomotion.